ETS1-dependent combinatorial control of oncogenic transcription in Notch-activated T-ALL

The discovery of NOTCH1 as the most prevalent oncogene in T-cell acute lymphoblastic leukemia (T-ALL)
patients raised hopes for targeted therapy in this cancer. Unfortunately, in clinical trials, the pan-Notch inhibitor
GSI caused dose-limiting toxicities, particularly intestinal, due to abrogation of Notch functions. Our idea to meet
this challenge stems from Drosophila studies showing that Notch requires co-binding transcriptional factor
partners at its response elements to generate cell-type specific gene expression programs. If these “Notch-
collaborating” transcription factors are hijacked to help drive Notch-induced T-ALL, then inhibiting them might
oppose Notch signals and circumvent GSI toxicities. Thus, our long-term goal is to identify Notch-collaborating
transcription factors and determine their potential as safe, therapeutic targets. In our preliminary data, we show
that ETS1 is the top-ranked Notch-associated transcription factor in the context of T cells, but not intestinal cells.
Compared to GSI, the effects of Ets1 inactivation were just as deleterious to T-ALL cells but were much milder
on intestinal homeostasis and overall health in mouse models. Mechanistically, we show that CDC73, the
scaffold component of the polymerase-associated factor complex (PAF1C), binds ETS1 and is recruited to
activate ETS1 response elements. One of these elements is a previously unrecognized but highly conserved
superenhancer, which we have tentatively labeled “E-Me” for “ETS1-dependent MYB enhancer”. Our objective
is to determine the effects of Ets1-dependent trans-factors and cis-elements on the control of oncogenic
transcriptional programs in Notch-activated T-ALL. We hypothesize that disrupting the ETS1-dependent
combinatorial control of transcriptional elements by targeting CDC73 or the E-Me will safely repress Notch-
induced T-ALL. To test this, we will determine the effects of inhibiting Ets1-dependent factors like Cdc73 on
leukemia maintenance in mouse and human models of T-ALL. We will also determine the effects of inhibiting
Ets1-dependent factors on oncogenic transcriptional programs and cis-element activation. Finally, we will
determine the role of the E-Me element where trans-acting factors are recruited by ETS1 to collectively drive the
oncogenic MYB effector pathway. Our work raises the possibility of targeting co-binding Notch-collaborating
transcriptional regulators like Ets1 that create the chromatin context that directs Notch functions. Here we will
establish Cdc73 as the bridge that connects Ets1 to transcriptional machinery and chromatin modifiers that
activate promoters and enhancer elements and highlight E-Me as an important example. Therefore, if successful,
our project is significant because we target the #1 ranked Notch-associated cofactor in a cancer to disable Notch-
driven oncogenic signals without the toxicities of pan-Notch inhibitors seen in clinical trials. This project is
innovative because, to our knowledge, no other Notch cofactor besides ETS1 has been shown to physically
recruit Notch to chromatin genome-wide with strong statistical and orthogonal rigor and with a strikingly high
convergence of Notch cofactor and Notch binding motifs that was validated by chromatin profiling.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it could reveal strategies to target the combinatorial control of Notch-dependent promoter and enhancer elements in T-cell acute lymphoblastic leukemia, a cancer affecting both children and adults and in which Notch inhibitors have been proven to be too toxic in early clinical trials. We discovered that ETS1 promotes enucleation of many oncogenic transcription factor players at Notch-responsive elements. In this proposal, we will learn how these players cooperatively interact and find ways to disrupt these interactions to target oncogenic Notch transcriptional programs and circumvent the toxicity of pan-Notch inhibitors.